Development of a Drug Candidate for the Treatment of Agitation in Alzheimer's Disease

PROJECT SUMMARY / ABSTRACT
Alzheimer’s disease (AD) is a highly prevalent neurodegenerative disease currently affecting approximately 6.2
million Americans. AD irreversibly damages the central nervous system, thereby inducing a variety of cognitive,
behavioral, and psychiatric disturbances that include agitation and aggression. AD aggression occurs in
approximately a third of AD patients and meaningfully reduces patient and caregiver quality of life. Currently
available pharmacological treatments for AD aggression center on the use of atypical antipsychotic drugs, which
have modest efficacy only after chronic administration, and are associated with sedation as well as adverse
events including increased rates of upper respiratory tract infections, cardiovascular events, falls, and mortality.
Given the modest efficacy and poor safety profile of these treatments, identification of novel treatments for AD
aggression with improved efficacy and safety is an important unmet need. The long-term goal of this project is
to bring to market a new treatment for AD aggression to improve the quality of life for people with AD and their
caregivers. We have discovered a lead drug candidate, PGI-5128, that has a novel mechanism of action to
produce serenic-like effects in rodent models of aggression. Phase I of this project seeks to evaluate the efficacy
of PGI-5128 in reducing aggressive behaviors in male and female transgenic AD (APP/PS1) mice. Phase II
seeks to initiate Investigational New Drug (IND)-enabling non-clinical safety and toxicology studies in rats and
dogs conducted according to good laboratory procedures (GLP). Specifically, studies will include 28-day repeat
dose toxicology studies with 14-day recovery periods in rat and dog, genotoxicology studies including in vitro
bacterial reverse mutation and in vitro and in vivo micronucleus tests, and safety pharmacology studies including
in vitro manual patch clamp-based measures at the human ether-à-go-go (hERG) channel, CNS and behavioral
and safety pharmacology studies in rats, a respiratory safety study in rats, and a cardiovascular safety study in
dogs. Completing these studies will position PGI-5128 for an IND application to allow evaluation in human
subjects.

Public health relevance
PROJECT NARRATIVE Agitation is a common neuropsychiatric feature of Alzheimer’s disease and other dementias that meaningfully reduces patients’ quality of life and adds to caregiver perceptions of burden. Unfortunately, there are few treatment options available for agitation in Alzheimer’s disease, and the available treatments are associated with an increased rate of mortality among elderly patients. This project will fund non-clinical efficacy and safety assessments of a novel drug candidate in preparation for evaluation in Alzheimer’s disease patients exhibiting agitation.